D-XYLOSE BREATH TEST--DOES IT COMPARE TO BIOAVAILABILITY OF D-XYLOSE

This protocol is designed to compare D-xylose pharmacokinetics and parameters of absorption with breath tests in patients suspected to have malabsorption.